Learning the visual and cognitive bases of lung nodule detection

Project Summary/Abstract
Lung cancer is the most frequent cause of cancer death in the United States among both men and women. If
lung nodules can be detected with greater reliability at an early stage, significant improvements in survival rate
would be achievable. Chest radiographs are among the most common diagnostic tool used in radiology, and
can reveal unexpected incidences of lung cancer. However, even expert radiologists may fail to detect the
presence of a subtle low-contrast pulmonary nodule against the high-contrast anatomical background of a
chest X-ray, with estimated rates of missed detection of 20-30%. What are the perceptual mechanisms,
cognitive mechanisms, and critical learning experiences that determine how well a person can perform this
challenging task of lung nodule detection? The PI and Co-Investigator have formed a synergistic collaboration
that brings together expertise in human vision, computational modeling and neuroscience (Dr. Tong) in concert
with thoracic imaging and biomedical engineering (Dr. Donnelly) to address this longstanding problem with high
clinical relevance. This project will develop a validated computational approach for generating a diverse set of
visually realistic simulated nodules to achieve the following goals. These are: 1) to characterize radiologist
performance on an image-by-image basis in an ecologically valid manner, 2) to develop a novel image-
computable model that accounts for expert performance, and 3) to develop a novel learning-based paradigm to
characterize the perceptual and cognitive mechanisms of nodule detection, initially in non-expert participants,
with the long-term goal of developing a protocol to enhance clinical training. The project will incorporate
sophisticated 2D image-based computational methods as well as data from 3D CT segmented nodules to
generate a diverse set of simulated nodule examples, each placed in a unique chest X-ray. Success will be
evaluated by the following outcome measures. First, radiologists should find it very difficult to tell apart real
from simulated nodules. Moreover, their performance accuracy at detecting/localizing simulated nodules
should be predictive of their accuracy for real nodules. Second, if the simulated nodules suitably capture the
variations of real nodule appearance, then non-expert participants who receive multiple sessions of training
with simulated nodules should show improved performance for both simulated and real nodules. This learning-
based paradigm will allow for characterization of the perceptual, cognitive, and learning-based factors that
govern nodule detection performance. Third, development and refinement of this learning-based paradigm
should have the potential to improve nodule detection performance in radiology residents. Finally, the
behavioral data gathered from radiologists and other top-performing participants will be used to develop an
image-computable model of nodule detection performance. As a whole, this project will lead to a more rigorous
understanding of the perceptual and cognitive bases of lung nodule detection, and spur the development of a
new learning-based protocol to enhance the training of radiology residents and other medical professionals.

Public health relevance
Project Narrative Even expert radiologists can find it challenging to detect the presence of a subtle, low-contrast pulmonary nodule in a chest X-ray, which could potentially indicate cancer. This project will develop a validated computational approach to generate a diverse and visually realistic set of simulated nodules in real chest X-ray images, in order to i) characterize radiologist performance on an image-by-image basis, ii) develop an image- computable model of expert performance, and iii) create a novel learning-based paradigm to characterize the perceptual and cognitive mechanisms of nodule detection. This project will provide foundational knowledge of the visual and cognitive processes that underlie expertise in nodule detection, and will promote the development of a learning-based protocol to enhance the diagnostic training of radiology residents and other medical professionals.